From Toddler to Early Adolescent Emotion Regulation Strategies

Project Summary/Abstract
Emotion regulation facilitates adaptive socioemotional functioning across the lifespan; ineffective emotion
regulation underlies difficulties in intra- and interpersonal functioning, including mental health difficulties.
Emotion regulation is typically assessed as behavioral regulation strategies in early childhood and as cognitive
regulation strategies by middle childhood and adolescence. Despite being theoretically linked by cognitive
capacities and emotion development, more broadly, there is virtually no knowledge about the link between
behavioral emotion regulatory strategies in early childhood and cognitive emotion regulation strategies in early
adolescence. Knowledge is particularly lacking for contexts of threat, which may highlight risk for adjustment
problems related to avoidance and withdrawal. This project will contribute to the scientific knowledge base of
emotion regulation development by leveraging existing data from an ongoing longitudinal, multimethod study to
test two specific aims and explore one additional aim. These aims will be examined in light of other well-
established correlates of emotion development (sociodemographic family characteristics, children’s verbal
ability and executive functions, parent mental health difficulties). Aim 1 is to test whether behavioral (self-
soothing, caregiver-focused, and distraction) emotion regulatory strategies at child age 3 predict avoidant and
engaged cognitive emotion regulation strategies at a follow-up assessment to be completed when children are
10-14 years old. In a previous phase of our broader longitudinal study, children’s regulatory behaviors were
elicited in laboratory tasks characterized by threat (novelty and uncertainty). Avoidant and engaged cognitive
emotion regulatory strategies will be assessed by children’s self-report, parent-report, and interviews with
children after they engage in laboratory tasks characterized by threat. To provide additional developmental
information, Aim 2 is to test whether child age at the follow up assessment (ranging 10-14 years) moderates
the relation between behavioral emotion regulatory strategies at age 3 and cognitive emotion regulatory
strategies in early adolescence. Finally, the Exploratory Aim is to test theoretically-supported individual (i.e.,
temperament) and environmental (i.e., maternal emotional environment) variables as potential mediators or
moderators of the relation between behavioral emotion regulatory behaviors at age 3 and cognitive emotion
regulatory strategies in early adolescence. Understanding the relation between behavioral and cognitive
emotion regulation across development will improve and expand current emotion regulation theory and inform
targeted socioemotional interventions, aligning with the National Institute of Child Health and Human
Development’s mission to ensure that all children reach their fullest potential.

Public health relevance
Project Narrative Emotion regulation is essential for adaptive intrapersonal and interpersonal functioning. Comprehensive theory and socioemotional interventions require an understanding of whether, how, and when the behavioral indicators of emotion regulation in early childhood connect to cognitive strategies for emotion regulation that emerge in early adolescence. Thus, to provide fundamental knowledge about emotion regulation development, the planned work under this application tests relations between behavioral emotion regulatory strategies for situations characterized by threat in early childhood and cognitive emotion regulation strategies in early adolescence.